Investigating Impacts of Neighborhood Disadvantage on ADRD risks, imaging biomarkers, and cognition

An estimated 6.7 million Americans are living with Alzheimer’s disease (AD) dementia in 2023, with more than 55 million people living with AD worldwide. However, stark differences exist in the prevalence of AD with older adults with multidimensional poverty being more than twice as likely to develop dementia during their lifetime. Resources, opportunities, and the environment where you live, work, play, and age have been proposed as significant predictors of numerous risk factors associated with dementia. This proposal will investigate the influence of a novel social factor, neighborhood disadvantage, on (1) cardiovascular and metabolic risk factors, brain imaging biomarkers, and (2) cognitive function associated with AD and related dementias (ADRD). This project will utilize data from the Wake Forest Alzheimer’s Disease Research Center (ADRC) Clinical Core Cohort to conduct analyses investigating these relationships. Training will take place at the Wake Forest University School of Medicine in the Molecular Medicine and Translational Science (MMTS) and Medical programs as a part of the M.D./Ph.D. dual-degree program. The applicant will receive training in the foundational knowledge necessary to conduct research using rigorous statistical methodology and analytical design, along with scientific writing and communication to accomplish the proposed aims. Mentorship for the proposal includes a multidisciplinary team with individuals in the ADRC, along with faculty in the Internal Medicine and Neurology departments. This team will provide the applicant with feedback every step along the way, regarding data analysis, interpretation of findings, and manuscript preparation. The proposed aims have the potential to provide new insights into the effects of one’s neighborhood-level disadvantage on various factors of risk associated with ADRD and further elucidate the influence of social factors on risk of dementia.

Public health relevance
The number of people who live with dementia, the impaired ability to remember, think, or make everyday decisions that interferes with daily activities, is increasing rapidly with some estimating a tripling of the number by 2050. With this increase in cases, existing disparities in who develops the disease will also continue to widen, with those living in poverty becoming more likely than they already are to develop dementia. This project will look at how where one lives might impact their risk for developing dementia, by considering the resources and opportunities that are available to them because of the neighborhoods they live in.